Molecular determinants of oxidative stress in Salmonella pathogenesis

ABSTRACT:
Almost two billion people worldwide become ill with diarrhea annually, and ~700,000 die. Nontyphoidal
Salmonella, such as Typhimurium, cause roughly 180 million diarrheal illnesses and 300,000 of all diarrheal
disease-associated deaths. Very young and very old people, as well as immunosuppressed individuals coinfected
with HIV or plasmodium, are particularly at risk of suffering life-threatening, systemic nontyphoidal Salmonella
infections. During infection, phagocytic cells bombard Salmonella with highly toxic reactive oxygen species
produced in the respiratory burst of the protein complex NOX2. The metabolic adaptations that promote growth of
Salmonella in macrophages are vital yet largely neglected facets in the pathogenesis of this intracellular bacterium.
In the current grant period, we made a series of crucial new observations regarding the hitherto poorly understood
terminal electron acceptors used by intracellular Salmonella to resist NOX2 killing. (a) Salmonella exploit
anaerobic respiration in order to avoid metabolic pathways particularly sensitive to reactive oxygen species
synthesized by NOX2. (b) The O2-consuming activity of phagocytic cells activates Salmonella anaerobic programs
in mice, macrophages and hypoxic culture conditions that recapitulate microabscesses developing during
Salmonella systemic infections. (c) Anaerobic respiration associated with dmsABC gene products is required for
survival of Salmonella in phagocytes and mice. (d) We have identified methionine sulfoxide, a byproduct of NOX2
enzymatic activity in mice, as the relevant terminal electron acceptor utilize by dmsABC gene products. (e)
Anaerobic respiration on methionine sulfoxide is associated with production of the antioxidant hydrogen sulfide
(H2S) in anaerobic Salmonella undergoing oxidative stress. (f) Intracellular Salmonella also respires on the sulfur
compound tetrathionate to avoid NOX2 killing in macrophages, while activating the expression of Salmonella
virulence programs. Cumulatively, our data support the hypothesis that intracellular Salmonella has coopted the
energetics and signaling pathways arising from a sulfur-centric anaerobic metabolism to counteract the damaging
activity of NOX2 enzymatic complexes in macrophages. Aim 1 will investigate the contribution of DmsA-dependent
anaerobic respiration to the resistance of intracellular Salmonella to NOX2. Aim 2 will evaluate the degree to which
hydrogen sulfide aids the defense of intracellular Salmonella against oxidative stress. Aim 3 will identify the
mechanisms through which tetrathionate respiration fosters the antioxidant defenses of intracellular Salmonella.
The knowledge generated in the course of these investigations will not only illuminate key aspects of Salmonella
pathogenesis but will also identify key terminal electron acceptors utilized by intracellular Salmonella to establish
a stronghold within professional macrophages.

Public health relevance
NARRATIVE: Humans naturally generate sterilizing “oxidative stress” products, such as hydrogen peroxide, to attack harmful invaders. We have discovered that in order to survive, pathogenic bacteria metabolize sulfur compounds produced by macrophages during oxidative stress. We seek to understand and exploit this process in order to benefit humans. Because oxidative stress occurs in many other illnesses, research into these novel anaerobic antioxidant defenses of harmful bacteria potentially has relevance to a wide variety of other diseases.